Aflatoxin exposure and hepatocellular carcinoma in Mexico

Project Summary
Aflatoxin B1 (AFB1) is a fungal contaminant in food that may be exerting a significant impact on the increasing
hepatocellular cancer (HCC) burden in Mexico. HCC epidemiology in Mexico is unusual given the low
prevalence of hepatitis virus B and C infection, similar HCC mortality among men and women, and a rural-
urban gradient. In Mexico, maize, a staple food, appears to be commonly contaminated by aflatoxins. Thus,
AFB1 contamination alone or in combination with non-viral risk factors may be driving HCC incidence rates.
We aim to provide initial data on the relevance of AFB1 for HCC in Mexico, while strengthening research
capacity for future needs. We specifically will (1) measure circulating AFB1 from 955 women and men from
four high HCC burden areas; and (2) create a research network to retrospectively identify aflatoxin-induced
mutations in liver samples and determine the feasibility of prospectively obtaining clinical information and
biospecimens from incident HCC cases. We will gain insight into HCC risk factors in a population with a unique
epidemiological pattern, demonstrate our capacity to access an existing biorepository that will become an
important resource for future environmental and cancer research, and create a strong research environment
that will foster future collaborative efforts with local, regional, and international scientists.

Public health relevance
PROJECT NARRATIVE The increasing burden of hepatocellular carcinoma in Mexico is not explained by the distribution of well-known risk factors. We aim to provide data on the relevance of aflatoxin B1 for hepatocellular carcinoma in Mexico, while strengthening research capacity by utilizing an existing biorepository and creating a research network to address future needs.